Empowering Annual Health Econometrics Workshop

Abstract
The Annual Health Econometrics Workshop (AHEW), www.healtheconometrics.org, provides a
forum to discuss the use of econometric and other quantitative methods to address issues in
health economics and policy, health services research, and outcomes research. The meeting is
the only one of its kind in North America and facilitates the exchange of ideas among the
growing number of health econometricians around the world. It allows for the considerable
exchange of ideas between junior and senior investigators in ways that no other health
economics or econometrics workshop in the US does. AHEW was inaugurated in 2009. The
2017 – 2019 workshops were funded by an R13 grant from AHRQ 2013 (R13HS025609) that
provided the much-needed support to establish this workshop as a premier meeting in the
world. We have seen record increases in paper submissions in last consecutive years, and
continued the workshop in 2020 in a virtual format. We are seeking renewal of our current R13
grant for the years 2021, 2022 and 2023. The venue for the 2021 workshop is tentatively
planned at the Emory University in Atlanta, GA. Venues for 2022 – 2023 are not yet finalized.
However, we have received overwhelming responses from researchers across the country
offering to host these workshops. We seek funds to enable us to continue to build a strong
workshop over the next three years and expand upon the scientific program to maximize
participation and interaction, scientific content, and dissemination and training efforts.

Public health relevance
NARRATIVE The Annual Health Econometrics Workshop (AHEW) provides a forum to discuss the use of econometric and other quantitative methods to address issues in health economics and policy, health services research, and outcomes research. The goal of this conference is to promote the understanding and applicability of econometric theory and models to develop statistical techniques that can be used in a wide range of settings including program and policy evaluations, comparative effectiveness research, health disparities research, evaluations of public health programs, quality improvements, and research prioritization. AHEW draws on a broad range of expertise from fields such as economics, statistics, sociology, epidemiology, health services research, and operations research; providing a forum for a unique interaction between pioneers and senior researchers in this field and junior researchers and students.